Characterize and optimize adjuvants to test monkeypox vaccines

To identify novel classes of adjuvants, characterize and optimize them, and test them in vivo with various antigens from different pathogens.